Defragmenting Care for Patients at Increased Risk of Hospitalization: A Conference on Comprehensive Care

Project Summary/Abstract
This application requests support for a novel 1-year dissemination and implementationconference grant in which
the University of Chicago Comprehensive Care Program (CCP) research team will engage ~50 healthcare
leaders and clinicians and social service providers in a hybrid in-person/virtual 1-day conference in Chicago and
monthly virtual sessions for the duration of the project period. The conference will focus on sharing dissemination
tools and implementation frameworks for evidence-based care delivery models that increase relational continuity
across inpatient and outpatient settings for patients at increased risk of hospitalization and explicitly address
both complex medical and social needs. This focus is motivated by evidence that greater continuity of care can
improve outcomes for patients at increased risk of hospitalization. This evidence includes studies of our
Comprehensive Care Program (CCP) that find that providing patients at increased risk of hospitalization access
to care from the same doctor in and out of the hospital can reduce hospitalization and improve health outcomes.
As a result of these positive findings, interest in implementing similar comprehensive care models has grown,
with several community and academic medical centers across the U.S. and internationally adapting CCP in their
settings with our guidance. This proposal builds on several years of successfully facilitating relevant learning
collaboratives that have engaged a diverse set of healthcare providers and health system types through virtual
meetings in the context of COVID-19, including a recent Comprehensive Care Grand Rounds virtual meeting
series. Participants in those meetings have expressed significant interest in building a community around
“comprehensive care” with in-an person convening opportunity to share implementation best practices and
evaluation methods.
We propose 3 specific aims for this conference grant:
Aim 1: To hold a conference in Fall 2023 that convenes stakeholders who have implemented or are interested
in implementing models of care that defragment care for patients at increased risk of hospitalization.
Aim 2: Through conference presentations and interactive workshops, to share tools and frameworks for how to
successfully implement and evaluate comprehensive care models in a range of health care settings to support
the dissemination of evidence-based comprehensive care models and the development of research to evaluate
these models at other sites.
Aim 3: To create and share deliverables for participants to continue to participate in dialogue and knowledge
sharing throughout the course of the year following the conference, including through a web-based forum to
facilitate relationship-building amongst participates and to house recordings fromthe conference workshops and
presentation and implementation and evaluation resources.

Public health relevance
Project Narrative This application requests support for a novel 1-year dissemination and implementationconference grant in which the University of Chicago Comprehensive Care Program (CCP) research team will engage ~50 healthcare leaders and clinicians and social service providers in a hybrid in-person/virtual 1-day conference in Chicago and monthly virtual sessions for the duration of the project period. The conference will focus on sharing dissemination tools and implementation frameworks for evidence-based care delivery models that create relational continuity across inpatient and outpatient settings for patients at increased risk of hospitalization and explicitly address both complex medical and social needs. This will be the first conference to focus on the topic of comprehensive care models, or models that defragment care for patients at increased risk of hospitalization, and through a full-day conference, monthly virtual convening opportunities, and conference deliverables, including a webpage with CCP dissemination tools and learnings, will reach a diverse set of health care stakeholders and patient populations that they serve.